Naive CD8 T cell functional heterogeneity

Project Summary
There has been considerable progress in identifying subsets in effector, memory, and exhausted CD8 T cells,
and our understanding of the role of each subset in response to infection has greatly improved. However, much
less is known about the heterogeneity of naïve CD8 T cells, the predecessors of these antigen-experienced T
cells. We have recently tackled this important issue, and our preliminary data show that there is a naïve CD8 T
cell population with a superior ability to generate more effector CD8 T cells after infection. A deeper
understanding of the naïve CD8 T cell heterogeneity will help to develop strategies to produce just such a better
naïve CD8 T cell population. Since naïve T cells have an enormous TCR repertoire diversity capable of
recognizing virtually any non-self antigens including pathogens and tumor neoantigens, making a high-quality
naïve T cell population that gives rise to potent effector and memory T cell responses would provide better
protection against known and unknown pathogens, enhance responsiveness to existing vaccines, and even
prevent the development of cancer. Our long-term objective is: To elucidate how naïve CD8 T cell heterogeneity
is generated and maintained and to understand qualitative differences among naïve CD8 T cell subsets;
Ultimately, to use this information to establish novel strategies to induce protective naïve CD8 T cell immunity
against pathogens and cancer. Toward this objective, we will investigate both mouse and human naïve CD8 T
cells. Our proposed studies in this application represent a new direction of research in the area of naïve CD8 T
cell heterogeneity. The following specific aims are proposed: Specific Aim 1: To elucidate how naïve CD8 T cell
heterogeneity contributes to immune response and homeostasis of T cells in mice. Specific Aim 2. To define
human naïve CD8 T cell atlas by examining antigen specific CD8 T cells in the young and aged adults as well
as newborns.

Public health relevance
Project Narrative There has been considerable progress in identifying subsets in effector, memory, and exhausted CD8 T cells, but much less is known about the heterogeneity of naïve CD8 T cells, the predecessors of these antigen- experienced T cells. A better understanding of the naïve CD8 T cell heterogeneity will provide crucial information toward developing rational approaches to target naïve CD8 T cells to enhance protective T cell immunity against pathogens and cancer.